A CHOLINERGIC NEUROCIRCUIT REGULATES FEEDING BEHAVIOR

PROJECT SUMMARY
Obesity is a major risk factor for many chronic medical conditions, including diabetes, cardiovascular disease,
depression, and cancer. Elucidating the neural networks that regulate feeding behavior and body weight control
is critically needed towards the development of effective strategies to combat obesity and its co-morbidities. We
recently found that the ventral subiculum (vSub), a component of the hippocampal formation, provides
monosynaptic inputs to the ventromedial hypothalamus (VMH). We further revealed that these VMH-projecting
vSub neurons are responsive to food, and chemogenetic activation of VMH-projecting vSub neurons suppresses
food intake in mice. However, we noted that the vSub→VMH circuitry has robust collateral projections to two
other brain regions, the lateral septum (LS) and the accumbens nucleus shell (AcbSh), which could also
contribute to the anorexigenic effects. Thus, our first objective is to systematically dissect which of these vSub
collaterals mediate anorexigenic action. Importantly, we will explore the physiological relevance of this circuit in
chronic feeding and weight regulation by using a mouse model with these vSub neurons genetically ablated. We
also found that cholinergic neurons in the diagonal band of Broca (DBBChAT neurons) provide extensive synaptic
inputs onto vSub neurons. The second objective of this research is to examine the effects of the DBBChAT→vSub
circuit on feeding, and to explore the physiological relevance of this upstream circuit in the chronic regulation of
proper feeding behavior and body weight control. Further, we found that vSub neurons abundantly express the
α7 subunit of nAChRs, and these cells can be activated by α7-nAChR agonists. Thus, the third objective of the
proposed research is to generate mice lacking α7-nChAR from vSub neurons, and use this model to elucidate
the physiological relevance of α7-nAChR within vSub circuitry towards feeding behavior and obesity
development. Together, these studies will rigorously examine the functions of both the downstream outputs and
upstream inputs of vSub neurons in feeding circuitry, and further identify the role of nAChR signaling in vSub
neurons that suppresses feeding. Accomplishment of these studies will fill a critical gap in knowledge by
identifying a novel neural circuit in the context of body weight regulation. Further, our results may provide needed
framework to develop novel therapeutic strategies towards obesity treatment.

Public health relevance
PROJECT NARRATIVE Complex neural circuits in the brain regulate feeding behavior. We recently identified a previously unknown 3- node neural circuit that connects the cholinergic neurons in the basal forebrain to the hippocampus, and then to the hypothalamus, and this circuit suppresses food intake. In the proposed research we will establish the functional relevance of this circuit in the regulation of feeding behavior and how it impacts long-term body weight control.